FISH OIL VS OLIVE OIL ON BLOOD CHOLESTEROL IN THE NEPHROTIC SYNDROME

Patients with nephrotic syndrome often have abnormalities in lipid metabolism. These may arise from increased synthesis of lipoproteins by the liver. This study is designed to test the effect of a dietary adjustment using fish oil versus olive oil (isocaloric diets) to examine the effect of dietary lipid composition on the synthesis of VLDL using a stable isotope, N15-luecine, as a tracer of VLDL kinetics and metabolism in subjects with nephrotic syndrome who consume a fish oil or olive oil enhanced diet for 6 weeks intervals.